BACE1 in neurodegeneration and neurological dysfunction

Abstract
Alzheimer's disease (AD) is the most common age-dependent neurodegenerative
disease with progressive impairment in synaptic and cognitive functions occurred early in
the disease course. For past three decades, various hypotheses are proposed to
determine the cause of AD pathogenesis. The amyloid hypothesis is being tested most
extensively in the field because of strong supports from human genetic and
epidemiological studies. The main essence of hypothesis is that the abnormal level of β-
amyloid peptide (Aβ) leads to sequential pathological developments that eventually cause
a potential of synaptic and cognitive dysfunctions in AD patients. Consistently, deletion or
inhibition of BACE1, which is a sole enzyme for cleaving amyloid precursor protein (APP)
at the β-secretase site to initiate the generation of Aβ, reduces Aβ production and amyloid
pathology. Brain penetrable inhibitors are tested in clinical trials but fail to improve
cognitive functions in AD patients, resulting in the early termination of clinical trials. We
and others show that BACE1 regulates synaptic plasticity and clinical used BACE1
inhibitors actually impair synaptic function at a clinically tested dose. In this proposal,
we aim to find solutions that will take the advantage of this plaque reduction and can
overcome the unwanted side effects associated with worsening cognitive
functions/scores. Our goal is to develop strategy that improve synaptic functions in
association with BACE1 inhibition in AD patients. We will test our central hypothesis that
BACE1 inhibitors will be more effective for AD treatment if BACE1-mediated synaptic
impairment is under controls. Two specific aims are proposed to test our hypothesis: Aim
1 is to differentiate toxic Aβ-mediated and BACE1-mediated synaptic impairments in
mouse models. Aim 2 is to determine whether mGluR1 positive allosteric modulator will
improve AD and BACE1-mediated synaptic impairment. The ultimate goal is to optimize
the use of BACE1 inhibitors and supplement with synaptic enhancer such as a positive
allosteric modulator (PAM) of metabotropic glutamate receptor-1 (mGluR1) in AD mice.
Our preliminary studies support shows improved long term potentiation in BACE1-null
mice treated with an mGluR1 PAM. Knowledge gained from this study will guide the
future clinical application of BACE1 in human.

Public health relevance
PROJECT NARRATIVE The abnormal accumulation of amyloid peptides (Aβ) are linked to cause Alzheimer's cognitive dysfunction. Inhibition of BACE1, a critical enzyme for the generation of Aβ, may prevent and reduce Aβ generation to avoid excessive amyloid deposition. This study aims to test how BACE1 inhibition will be more effective in treating Alzheimer's patients. We aim to develop approaches that will enhance synaptic strength in addition to reduce Aβ generation. The obtained results will provide timely guidance for the safe and effective use of BACE1 inhibitors in human.